Supporting the implementation of a state policy on screening for Adverse Childhood Experiences (ACEs) in Federally Qualified Health Centers

PROJECT SUMMARY
Adverse Childhood Experiences (ACEs) are defined as traumatic events occurring before age 18, such as
maltreatment, life-threatening accident, harsh migration experiences or exposure to violence. ACEs are
pervasive, with 45% experiencing at least one ACE and 10% experiencing three or more ACEs, placing them
at high risk for negative life outcomes. ACEs are more prevalent among minority and immigrant communities
due to exposure to poverty, discrimination, community violence, national disasters, and refugee experiences.
ACEs screenings have potential value in identifying children experiencing toxic stress and the physical and
mental health conditions associated with it such as asthma, ADHD and anxiety. Yet, they are seldom used in
primary care during well-child visits. The Surgeon General of the state of California has addressed this care
gap by issuing an ACEs screening policy. Starting January 2020, MediCal, California's Medicaid health care
program, will reimburse primary care settings ($29) for using the Pediatric ACEs and Related Life-events
Screener (PEARLS) tool to screen children for ACEs during wellness visits. Despite significant investment in
California and nationwide, evidence of the public health value of universal child screening policies is unclear.
Increased screening efforts often do not translate into higher access to care for children and may even
exacerbate disparities by increasing stigma and reinforcing a deficit view of marginalized groups. These results
have been attributed to a lack of rigorous studies testing implementation strategies suited for pediatric
screening policies. This mixed-method study will fill this gap by refining and testing an implementation strategy
using a multi-site control trial with a Federally Qualified Health Center in Southern California. Using the EPIS
framework, we will employ a hybrid (type 2), randomized controlled trial using a stepped-wedge design (n=5
clinics) to test to test a central hypothesis that clinics employing a multifaceted implementation strategy will
have higher fidelity and reach of the ACEs screening policy. A secondary hypothesis will examine the public
health impact of the ACEs policy on child patient-level mental health service and symptom outcomes. Specific
aims are: Aim 1. Refine a multifaceted implementation strategy to support the implementation of the ACEs
screening policy in community-based clinics, and Aim 2. Pilot test the feasibility, acceptability, fidelity and reach
of the implementation strategy and the impact of the ACEs policy on child patient-level outcomes. This project
capitalizes on a rare opportunity to pilot test an implementation strategy to maximize the impact of a state-wide
policy intended to improve child health in under-resourced settings.

Public health relevance
PROJECT NARRATIVE Adverse Childhood Experiences (ACEs) are pervasive among children with 45% experiencing at least one ACE and 10% experiencing three or more, placing them at high risk for toxic stress and symptomatology. Yet, ACEs often goes undetected in primary care settings during well-child visits due to unclear policies and tested implementation strategies. This study will use mapping methodology, guided by the EPIS framework, to refine a multi-faceted strategy supporting the implementation of the state of California's 2020 policy promoting universal ACE screening in community clinics, and a stepped-wedge design trial to test the impact of the strategy on implementation and child-level outcomes.